Statistical Methods for Alzheimer's Research

The main theme of the research is to develop new methodologies for resolving statistical issues emerging from
our team's collaborations in cohort studies of underrepresented and overall US aging populations with a
particular interest in Alzheimer's disease (AD). We focus on making appropriate statistical inference for censored
survival data with partially known risk sets, developing methods for assessing prediction precision for recurrent
events survival data including time-dependent ROC and extension of the C-index, and developing new
conditional modeling strategies that best model life history processes during the lifespan. We also plan to
develop publicly available statistical software with the goal of dissemination and generalization.
The proposed methods of estimating time-dependent ROC and C-index for recurrent events extend those for a
single survival time by taking into account different models for recurrent events, producing novel predictive
models for recurrent events when there are possible missing events. Such predictive models are useful in
estimating the partially observed risk sets which would lead to appropriate parameter estimation in regression
analysis for censored survival data, in particular, time of AD onset, using the proposed weighted estimating
approaches. In AD research, death as a terminal event occurs frequently in aging cohorts. The proposed
conditional modeling strategy allows us to investigate AD events during the entire lifespan, which provides a
clearer picture of the relationships among AD onset, death, other life evens, and risk factors, thus a better
understanding of AD etiology and prevention. The method also provides a straightforward thus more precise
estimation of AD prevalence that is potentially impactful to health care policy making. These methods are
motivated from and will be applied to a wide range of datasets, including the Indian Health Service – a unique
source for studying the disproportionate burden of AD among Native American populations, the Aging,
Demographics and Memory Study – a subset of the Health and Retirement Study representing an ideal
observation cohort study for studying the epidemiology of AD in the Black and Latinx communities, the National
Alzheimer's Coordinating Center uniform data sets collected by more than ADRCs in the US from their
longitudinal cohorts, the 90+ study that focuses on aging and dementia of the oldest old population, and the CMS
Limited Data Set that is a random sample of Medicare/Medicaid claims data accessible for research purposes –
the most representative data of the US aging population. The methods will be widely applicable to problems in
many other fields of biomedical research.

Public health relevance
The application is intended to resolve critically important issues emerging from analyzing censored data in longitudinal cohort studies. These issues include how to make appropriate statistical inference for censored survival data when risk sets are partially observable, how to best predict possibly missing recurrent events, and how to reasonably model effects of terminal events on life history processes. This proposal is directly motivated by the investigative team's research in aging and Alzheimer's disease.